Impact of Dietary Fructose and High Salt Diet on Neurocardiovascular and Renal Function

Program Director/Principal Investigator (Last, First, Middle): Rossi, Noreen F.
Nearly half of US adults have hypertension. Fructose intake predisposes to salt-sensitive hypertension, an
independent risk factor for major adverse cardiovascular events (MACE) and chronic kidney disease (CKD).
Increased salt intake impairs vascular compliance even before frank hypertension develops. Aortic stiffness is
now recognized as a robust predictor of MACE and CKD. Sympathoexcitation increases cardiovascular risk and
strongly impacts aortic stiffness. Our preliminary data show that combined fructose and salt intake contributes
to insulin resistance and hypertension that displays increased renal sympathetic activity and aortic as well as
renal artery stiffness. The goal of this application is to achieve early identification and timely intervention of
vascular stiffness to mitigate MACE and CKD. Robust, rigorous preclinical data are needed to justify testing and
treatment. Our central hypothesis is that a diet moderately high in fructose and salt (FHS) results in hypertension,
vascular stiffness and renal dysfunction driven by sympathetic nerve activity (SNA) and/or the renin-angiotensin-
system (RAS). We propose to interrogate the mechanism that this neuroexcitation and increased RAS are driven
by afferent inputs from the kidney to the brain at the subfornical organ and, thence, to SNA and/or
angiotensinergic inputs to heart, vasculature and kidney. Direct interruption of the afferent renal nerves, SNA or
pharmacological inhibition of SNA or RAS, alone or in combination, will decrease blood pressure, conduit
vascular compliance, and ameliorate cardiac and renal function. We propose three aims: 1) ascertain the
respective contribution of afferent vs efferent renal nerves on blood pressure, LV function, vascular compliance,
and renal function in FHS rat model, 2) assess the impact of acute or chronic pharmacologic blockade of SNA
and/or RAS on LV function, vascular compliance and renal function in FHS rats, and 3) evaluate the contribution
of the arterial baroreflex, AT1R and TNFR1 in the subfornical organ that lies outside the blood brain barrier on
blood pressure, LV-GLS, PP, PWV, RRI and renal function in rats on FHS diet. RAS and aortic compliance
display sexual dimorphism, so we will evaluate Sprague Dawley rats of both sexes. We will use state-of-the-art
ultrasonography, real-time renal blood flow and FITC-sinistrin measurements of glomerular filtration rate to
assess aortic and renal artery compliance, LV and renal function. We will directly assess the impact of afferent
and efferent renal nerves with selective deafferentation vs total denervation in conscious rats. We will validate
the in vivo findings by ex vivo myography of aortic rings and assess markers of oxidative stress in vasculature.
We will test whether chronic pharmacologic therapies to inhibit sympathetic inputs and/or RAS will also achieve
improvements in conduit vascular compliance, cardiac and renal function. Our studies will identify therapeutic
interventions that can be translated to screening and treatment of humans with pre-diabetes and stage 1
hypertension to improve vascular and renal function to mitigate MACE and CKD.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page

Public health relevance
Nearly half of the adult U.S. population suffer from hypertension, a major risk factor leading to heart disease, stroke, and kidney failure. Combined intake of fructose and salt equivalent to three 12-oz cans of sugared soft drinks and ~6 gm of sodium raises blood pressure, induces prediabetes, and increases stiffness of the arteries, all strong predictors of cardiovascular morbidity and mortality. Our proposal investigates drug therapies that improve blood pressure, insulin sensitivity, and arterial stiffness in a preclinical model and provides insights into underlying causes leading to novel approaches at an early stage of these disorders and prevent frank disease.